Mechanisms of cell shape change in cytokinesis

Project Summary
Cytokinesis is the physical division of one cell into two. This final step of the mitotic or meiotic cell cycle
partitions the duplicated and segregated genome into topologically distinct daughter cells, and thus ensures
genome stability. Cytokinesis is essential for development of the fertilized egg into a multicellular organism, for
the replenishment of tissues to compensate for wear and tear, and to avoid diseases of proliferation including
cancer and some neutropenias (blood cell disorders). For over a century, people have marveled through the
microscope at dividing animal cells, but major questions about the mechanisms of cytokinesis remain. Many of
these questions fall under the three Themes of our research program: 1) the cytoskeletal rearrangements that
drive contractility, 2) the role of feedback loops in cytokinetic regulation, and 3) modeling the mesoscale.
In animal cytokinesis, the cell changes shape as a furrow forms at the cell equator, the region between
the two masses of segregated chromatin, as defined by spatio-temporal cues from the anaphase spindle. These
cues lead to local activation of RhoA at the plasma membrane. RhoA elicits non-muscle myosin II (NMMII)
filament assembly and activity, the generation of long actin filaments (F-actin) by formins, and the cortical
recruitment of crosslinkers including anillin and septins. In sum, a circumferential band of cortical actomyosin
cytoskeleton assembles and contracts via rearrangement of these cytoskeletal components. F-actin is slid,
bundled, crosslinked and coupled to the plasma membrane, polarity sorted, bent, broken and depolymerized.
The biophysics of many nano-scale binding partnerships are well studied, but often with sparse collections and
without confinement. Since the relative contributions of the many activities listed above to in vivo network
dynamics are unknown, our first theme is to define the cytoskeletal remodeling that underlies contractility.
After spindle cues pattern the cell equator, both biochemical and mechanical positive feedback boosts
these signals. Concurrently, global and localized inhibition via negative feedback limits RhoA activity. Our
unpublished observations of contractile oscillations suggest that multiple negative feedback loops coexist. The
second theme of our work is the role of feedback loops in cytokinetic regulation.
To develop a conceptual model of cytoskeletal rearrangements in cell division, one may imagine the
nanoscale molecules and fibers and their millisecond behaviors literally woven into a dynamic material. Like
biophysics and cell biology, respectively, mathematical modeling also describes cytoskeletal rearrangements at
these two ends of the time- and length scales, via distinct approaches: particle-based modeling (nano- or micro-
scale), or continuum mechanics theory (macro-scale). Since both families of approaches have limited ability to
coarse grain the mesoscale spatial and temporal heterogeneities of the cytokinetic ring components’ activity
states, behaviors, abundances, and combinations, we are working to understand cytokinetic cytoskeletal
rearrangements and integrated regulation, by innovating methods to model the mesoscale (theme three).

Public health relevance
Project Narrative An animal cell, as a self-contained unit of life, contains all the components it needs to execute tasks like pinching in half. For example, cells possess a network of miniscule chemical motors and fibers that rearrange to generate the forces responsible for the cell shape changes. We use microscopes to gain magnified views of this dynamic network and to test how it rearranges differently if we manipulate one component at a time.